The DOVE Device to Prevent Opioid Overdose Deaths: An Armband That Senses Overdose and Automatically Injects Naloxone

ABSTRACT / PROJECT SUMMARY
Despite the wide availability of the antidote naloxone, fatal opioid overdoses still occur at a rate of ~50-70,000 /
year in the US. The problem is that naloxone requires a bystander to find and diagnose the overdose, find
someone who has naloxone, and then properly administer it. Unfortunately, if this does not occur within 5
minutes, the patient will suffer from brain damage, which is often considered the “hidden epidemic” underneath
the opioid death epidemic. Additionally, ~52% of opioid overdose deaths occur when the patient is totally
alone, without nearby bystanders around.
To solve these problems, here we introduce the DOVE device, which is an armband that detects an opioid
overdose via pulse oximetry and accelerometry, and then automatically injects an antidote. Our collaboration
between industry and academia has already moved forward the DOVE technology significantly: We published
a paper showing 76% of persons who use opioids (PWUOs) (n=97) expressed a strong desire for a device like
DOVE, and showed a strong preference for an armband over many other device designs. We next
preliminarily validated the other technical challenges of DOVE: we showed our sensor’s accuracy was high on
healthy volunteers with induced hypoventilation; and our autoinjector injected reproducibly into bench-top
models of skin/fat/muscle. Additionally we validated the market, reimbursement, sales channels,
freedom-to-operate, and regulatory path.
In this STTR grant, we will optimize & test the 3 major components of DOVE (harness, sensor, and injector): In
Aim 1, we will optimize and validate the harness which keeps the device position on the deltoid muscle. We
will do this with structured interviews and observations of PWUOs interacting with each of 6 harness
prototypes. In Aim 2 we will test if the DOVE sensor can accurately detect hypoxemia in sleeping patients.
Overdose events are relatively rare, so to increase the probability of detecting hypoxia using the DOVE’s pulse
oximeter, we will apply 2 DOVE pulse-oximeter prototypes (a finger-ring, and one placed on the shoulder skin)
to 20 obstructive sleep apnea (OSA) patients already undergoing sleep studies. We will compare the DOVE’s
pulse oximeter and accelerometry traces vs. those of FDA-approved devices. Finally, in Aim 3 we will optimize
the DOVE auto-injector to meet the size & shape constraints specified by PWUOs, and to accurately inject into
fresh, cadaveric pigs.

Public health relevance
NARRATIVE Overdose with opioids (drugs similar to morphine, such as heroin) causes subjects to stop breathing enough and suffocate. An antidote to opioid overdose, naloxone, is widely distributed, but it requires a bystander to identify a person overdosing, obtain naloxone, and inject it properly; all within < 5 minutes to prevent brain damage, and somewhat longer to prevent death. Therefore, we have invented the DOVE device, which is an armband that detects opioid overdose and automatically injects the antidote, and we will further develop and test it here.